Developing ultrasound contrast agents and signal processing for structural and functional imaging in type 1 diabetes

Enter the text here that is the new abstract information for your application. This section must be no longer than 30 lines of text.
N/A – Summary/Abstract remains unchanged.

Public health relevance
N/A – Public Health Relevance remains unchanged SPECIFIC AIMS Type 1 diabetes (T1D) results from the destruction of insulin producing β-cells upon immune infiltration and inflammation of the islets of Langerhans in the pancreas (insulitis). Lifelong insulin therapy is required, although patients remain at risk for both chronic diabetic complications and potentially fatal hypoglycemia. Prior to clinical onset of T1D there is an asymptomatic phase of many years during which β-cell mass and function progressively declines but glucose homeostasis remains normal. This ‘pre-symptomatic’ phase presents a window for therapeutic intervention. Indeed, immune therapies under investigation have shown some success in blunting β-cell decline, with antiCD3 recently receiving FDA approval. However, there are limited means for detecting and tracking the development of insulitis in this ‘pre-symptomatic’ T1D window to guide therapeutic interventions. Further, there is a complete lack of means to track the response to preventative treatment, prior to T1D onset. Clinical imaging modalities have been investigated to detect signatures of insulitis and β-cell decline but have either shown limited success in human subjects or are not practical for widescale deployment. Ultrasound imaging presents many advantages for clinical deployment, including widespread availability and absence of ionizing radiation. Gas-filled microbubble (MB) contrast agents are clinically approved, and are used in detection, therapy and monitoring of a wide range of diseases. We previously used contrast-enhanced ultrasound to detect signatures of insulitis in pre-clinical models based on factors such as altered pancreas perfusion or microvascular leakiness that occur during T1D. While these studies provide support for using contrast-enhanced ultrasound to guide and track therapeutic interventions in ‘pre-symptomatic’ T1D, there exists high potential for further advancements. A key limitation of pancreas imaging in T1D is that islets of Langerhans represent only a few % of the pancreas volume, diluting any disease signature by background signal and reducing sensitivity. Thus, high-resolution approaches are needed to view the specific disease signatures in T1D. Ultrasound localization microscopy (ULM) is an emerging super-resolution microvascular imaging technique that provides microvessel-level spatial resolution noninvasively in vivo, thus potentially enabling the resolution of specific T1D disease associated changes in the pancreas. Our overall goal is to apply ULM and signal processing in combination with novel ultrasound contrast agents to detect disease signatures associated with T1D, to provide image-based guidance and tracking of therapeutic interventions. We will conduct 3 specific aims: Aim 1: Ultrasound localization microscopy of vascular impairments in the pancreas. The pancreas microvasculature and blood flow change during T1D progression. We will perform ULM with size isolated MBs (SIMBs; 1, 3 & 5 µm diameter), where SIMBs are highly echogenic and will optimize ULM efficiency. ULM will be used to noninvasively map the pancreas microvasculature and flow dynamics to identify vascular impairments associated with insulitis in T1D progression, using murine models. These measurements will be compared with histological analysis of islet microvasculature and insulitis. Aim 2: Mapping the distribution of nanodrop accumulation and microvascular leakiness across the pancreas. Increased microvascular permeability occurs in the pancreas upon chronic inflammation during T1D. Nanodrops (NDs) accumulate within the islet microenvironment during T1D and provide contrast following acoustic vaporization. We will synthesize long-circulating ‘size-isolated’ NDs (SINDs; 0.2, 0.6 & 1.0 µm diameter), that vaporize at clinical MI (<0.7) and provide improved stability. We will characterize the biodistribution of these SINDs and their specificity to accumulate within the infiltrated islet microenvironment, using both ultrasound contrast imaging with histological analysis, in murine models of T1D. We will also assess conditions where ND vaporization minimizes transient or permanent impact on the islet microenvironment. Aim 3: Apply molecularly targeted microbubbles and nanodrops to the inflamed and infiltrated islet microenvironment. We will target best performing, optimal sized SIMBs to endothelial cell surface markers of inflammation by incorporating peptide ligands against P-, E- and L-selectin. We will use a buried-ligand surface architecture, where the ligand is protected from complement activation by a PEG overbrush, but which can bind its target marker upon application of ultrasound radiation force. Additionally, we will develop an individual bubble tracking approach to determine binding strength of adherent MBs. We will characterize the sensitivity and specificity of target binding in vitro, and perform similar measurements in vivo in models of T1D. Impact: Assessing inflammation and immune infiltration in the islet microenvironment using contrast-enhanced ultrasound imaging represents a fundamentally new paradigm for diagnosing and tracking T1D progression during the pre-symptomatic phase of disease. The development and application of size isolated microbubbles, nanodrop agents and functionalized microbubbles, and use of super-resolution ULM techniques, represents further innovations which will have broader impact. Therefore, outcomes of this project will aid in diagnosing both the pace of T1D progression and the efficacy of any preventative treatment prior to clinical onset. There also exists viable routes to the clinic for both the contrast agents and ULM techniques for early disease monitoring.